Brain MC4R-BAT-Heart crosstalk: a potential new therapeutic target for myocardial ischemia/reperfusion injury

PROJECT SUMMARY:
Ischemic heart disease is the leading cause of death in U.S. and timely reperfusion of the occluded coronary
artery after myocardial infarction (MI) is the most effective therapy currently available. However, additional
ischemia/reperfusion (I/R) injury occurs in ~25% of patients who suffer MI and these patients often develop heart
failure (HF). We recently demonstrated that activation of the brain leptin-melanocortin system pathway greatly
improves cardiomyocyte energy metabolism and contractility, preserves cardiac function, and prevents
progression of HF following I/R injury. Intracerebroventricular (ICV) infusion of leptin for 4 weeks, at a low dose
that did not alter blood leptin concentration, improved cardiac function and metabolism after I/R injury. We also
observed that these cardiac protective effects were absent in melanocortin 4 receptor (MC4R) deficient rats and
that direct activation of brain MC4R using synthetic agonists (e.g. MTII), circumventing leptin signaling, also
protected the heart from progressive cardiac dysfunction after MI. How the brain communicates with the heart
during leptin-melanocortin system activation is still unknown. Our preliminary data suggest that the
cardioprotective effect of ICV leptin or MTII infusion after I/R may be mediated by brown adipose tissue (BAT)
since BAT surgical removal and BAT sympathectomy markedly attenuated the effects of central leptin or MTII
administration to improve heart function post-I/R. Since obesity, a major cause of cardiovascular diseases, may
induce leptin resistance, we will focus on activation of central MC4R pathway, bypassing leptin resistance.
Therefore, we propose that activation of brain MC4R, via infusion of MTII directly into the brain, increases
BAT activity through the sympathetic nervous system; once activated, BAT releases extracellular
vesicles (EVs) containing cardioprotective microRNAs that reach the heart via the circulation and
improve cardiac function and metabolism post-I/R. Our Research Strategy is organized in two aims. Aim 1
will test the hypothesis that BAT-derived EVs are essential for the cardioprotective actions of activating brain
MC4R after cardiac I/R injury. Aim 2 will test the hypothesis that chronic activation of brain MC4R increases
BAT-derived EVs that protect the heart from I/R injury by delivering cardioprotective microRNAs, including miR-
125b-5p. We will use state-of-the-art chronic in vivo protocols with high-resolution ultrasound techniques for
imaging cardiac function in rats and mice combined with sophisticated molecular techniques for identification of
the BAT-derived EVs cargo. Outcomes from this study could lead to novel and more effective therapeutic
approaches for I/R and HF, and will provide a new target for MC4R agonists which are currently being used to
treat rare forms of genetic obesity in humans.

Public health relevance
PROJECT NARRATIVE: Cardiovascular diseases are the leading cause of mortality and morbidity in the United States and worldwide. Current therapies for heart failure after myocardial infarction offer only limited benefit and new, more effective treatments that can slow/halt disease progression and improve heart function are desperately needed. The primary focus of this proposal is to understand the mechanisms by which activation of the central nervous system melanocortin system improves cardiac metabolism and prevents progression of heart failure after myocardial ischemia/reperfusion injury, and the role of brown adipose tissue in mediating these cardioprotective effects.